Protocol Review and Monitoring System

The purpose of the University of Hawai'i Cancer Center (UHCC)'s Protocol Review and Monitoring System (PRMS) is to ensure that clinical research of the highest scientific quality is carried out under UHCC sponsorship. It reviews and monitors all clinical trials where a UHCC faculty member is the Principal Investigator or where UHCC resources are utilized. The responsibility of the PRMS is to assure scientific quality of protocols, assure that protocols meet UHCC scientific priorities, and assure adequate scientific progress through satisfactory accrual and the continuing importance of protocol objectives.

Public health relevance
PRMS assures that the contributions of patients participating in Center protocols provide impactful new knowledge about how to reduce the burden of cancer and are not wasted through inadequate science or protocol progress.